Expanding the reach of cancer genetic services to underserved Spanish-speaking Latina women

PROJECT ABSTRACT
This application is being submitted in response to the Notice of Special Interest (NOSI) identified as “NOT-OD-
22-208” as a supplement to the Huntsman Cancer Institute (HCI) Cancer Center Support Grant
(5P30CA042014-33). The proposed project would directly address Strategic Goal 3.1 from the 2019-2023
Trans-NIH Strategic Plan for Women’s Health Research, Advancing Science for the Health of Women: Design
and test approaches to promote the adoption, adaptation, and integration of evidence-based interventions in
public health, clinical practice, and community settings. The project would also address areas of emphasis in
NOT-OD-22-208, including studies seeking to identify novel dissemination and implementation approaches to
reach underserved, understudied, and underrepresented populations of women. In prior work, we implemented
a standards-based software platform coupled with algorithms that identify patients who meet criteria for cancer
genetic testing based on family history data. In the Broadening the Reach, Impact, and Delivery of Genetic
Services trial (U01CA232826), we are comparing uptake of genetic testing for an automated tool (i.e., chatbot)
vs. standard of care cancer genetic services delivery models for 1300 patients identified by the algorithm. Our
prior work has identified substantial disparities in the presence and comprehensiveness of cancer family
history data in the electronic health record, leading to under-identification of Spanish-speaking and Latinx
patients by the algorithm. Preliminary data are also indicating lower uptake of the Spanish language chatbot in
our current trial. Combined with prior data showing lower utilization of cancer genetic services among Latinx
patients, it is critical to adapt approaches to better reach Spanish-speaking Latina women. Our team has
utilized the mobile HCI Cancer Screening and Education Bus to conduct family history screening with Spanish-
speaking Latina women, and has found substantial interest in cancer genetic counseling and testing in this
community. We therefore propose two Supplemental Specific Aims. Aim 1 will utilize a multi-method
ethnographic workflow analysis to characterize intervention points to utilize automated tools to identify
Spanish-speaking Latina women eligible for cancer genetic evaluation and offer genetic services. Aim 2 will
utilize community engagement and user-centered design methods to investigate the cultural and linguistic
suitability of automated tools created in our prior work and test the feasibility of using culturally tailored
automated tools with this community. The proposed project relates directly to an aim of the HCI Cancer Center
Support Grant: to effectively and compassionately address the needs of our service area through state-wide
alliances, community-based services, and impactful research, with a focus on areas of high cancer incidence
and mortality in Utah, as well as health disparities. The project also aligns with HCI’s goal to lead the
translation of cancer genetic services to the population, including underserved populations.

Public health relevance
PROJECT NARRATIVE The proposed supplemental project will address important gaps in care of Latinx and Spanish-speaking women by developing and testing interactive, automated, and scalable approaches to identifying unaffected women who meet criteria for cancer genetic evaluation based on their family history and delivering services in community-based workflows. The project will directly address national priorities by focusing on novel dissemination and implementation approaches to reach underserved, understudied, and underrepresented populations of women as well as add substantial value to the Huntsman Cancer Institute Cancer Center Support Grant by addressing critical health disparities in our service area and meeting our strategic vision of leading the translation of genetic services to the population, including underserved communities.